Shared Resource 02: Biospecimen Services (BSSR)

PROJECT SUMMARY – BIOSPECIMEN SERVICES SHARED RESOURCE (BSSR)
The mission of the BSSR is to support innovative translational research to advance the prevention, diagnosis,
and treatment of cancer through the provision of biospecimens and clinical data. The Specific Aims are to: 1)
collect data and specimens from OSUCCC cancer patients using the IRB-approved Total Cancer Care (TCC)
universal consenting and biobanking protocol for future unspecified research; 2) prospectively procure
biospecimens for specific IRB-approved protocols; and 3) provide high quality, centralized biorepository services
for IRB-approved, grant-funded and large institutional projects in a CAP-accredited biorepository. Over the
current grant cycle, the major changes for the BSSR include: a) implementation of TCC across all Disease
Specific Research Groups (DSRGs) covering all cancers - TCC now includes 57,256 consented subjects
resulting in regular usage of biospecimens and data; and, b) the ORIEN AVATAR program was initiated,
providing OSUCCC members with research grade next generation exome sequencing results on tumor and
normal tissue with clinical annotation from 3,049 TCC subjects at OSU and 11,500 across ORIEN (the OSUCCC
is a major contributor of samples). During the current grant cycle, the BSSR provided key services in support of
122 publications (35 > 10 impact factor), 105 users, and 24 NCI grants, including 1 K01, 1 K12, 2 P01s, 2 P50s,
11 R01s, 4 R21s, 1 U10, 1 UH2, and 1 UM1. Over the next grant cycle, BSSR will contribute to each of the new
strategic priorities for the OSUCCC by providing biospecimens and high quality genomic and clinical data as
requested by immuno-oncology, translational genomics, cancer engineering and cancer prevention and
survivorship investigators. Each area will be supported by the TCC, and given the robust faculty recruitment and
regularly increasing patient volumes; there will be an increase in prospective procurement and biobanking as
well. Given the robust OSUCCC recruitment and increasing patient volumes, demand for services and new
technologies will increase. The BBSR will expand its staff, instrumentation and services before capacity is
reached. The annual budget of the BSSR is $2,206,277, yet the CCSG request is $179,168. As such, The BSSR
leverages extensive institutional support and seeks only 8.1% support from CCSG funds.